Neurocomputational mechanisms of explore-exploit decision making in prefrontal and motivational neural circuits

Project Summary
The explore-exploit dilemma refers to the challenge of deciding when to forego choices with known
consequences to explore new opportunities and learn more about them. Managing this trade-off is a fundamental
component of behavioral flexibility. Excessive exploration or exploitation impedes learning and results in poor
choices leading to undesired outcomes. Explore-exploit decision making is understudied in psychiatry despite
its ecological validity and relevance in understanding disorders characterized by inflexible behaviors. One reason
for this is we have not identified if the brain encodes information relevant for managing explore-exploit tradeoffs
differently when exploration is motivated by either appetitive or aversive consequences. Another reason is that
while there is evidence in humans that frontopolar cortex—the most anterior part of prefrontal cortex which is
unique to primates—implements decisions to explore new opportunities, the neural mechanisms underlying
changes in frontopolar activity that prompt exploration are unclear. Neurons in the orbitofrontal cortex,
basolateral amygdala, and nucleus accumbens encode value signals that inform explore-exploit decisions. This
suggests a more dynamic interplay between frontopolar cortex and motivational brain regions during explore-
exploit decision making than is currently hypothesized. This proposal tests the hypothesis that frontopolar cortex
implements decisions to explore, but is reliant on appetitive and aversive value signals computed in motivational
neural circuits to balance exploration and exploitation. We predict that bottom-up feedback to frontopolar cortex
from brain regions classically associated with signaling reward value is critical for balancing exploration and
exploitation. In Aim 1 we will test if monkeys explore more often when choices in a multi-arm bandit task are
associated with gains or losses, and use computational modeling of choices to define valence dependent
differences in their willingness to explore. In Aim 2 we will simultaneously record neural activity in frontopolar
and orbitofrontal cortex, basolateral amygdala, and nucleus accumbens to determine if bottom-up information
flow from motivational brain regions to frontopolar cortex predicts decisions to explore or exploit, and if
exploratory choices are encoded differently when exploration is motivated by gains versus losses. In Aim 3 will
use pathway-specific chemogenetics to excite or inhibit basolateral amygdala neurons that project to the nucleus
accumbens, while recording neural activity in the nucleus accumbens and frontopolar cortex. We will to test the
prediction that excitation of this pathway increases exploitation due to heightened encoding of exploitative signals
in nucleus accumbens and decreased encoding of exploration signals in frontopolar cortex. Upon completion of
these aims, we will understand how imbalances in explore-exploit decision making emerge in different psychiatric
disorders based on the integrity of prefrontal cortex and motivational circuits.

Public health relevance
Project Narrative Deciding whether to explore a new opportunity or exploit what already has been learned is a fundamental component of behavioral flexibility. Unbalanced exploration or exploitation can have dramatic consequences on well-being and quality of life, however, explore-exploit decision making is understudied in psychiatry because the neural mechanisms underlying it are not well understood. The research in this grant will uncover the neural mechanisms underlying explore-exploit decision making and determine if different cortical and subcortical circuits are engaged when the motivation to explore novel opportunities is driven by a desire to maximize gains or minimize losses.